Rhode Island Child Clinical Trials Collaborative

The Rhode Island Child Clinical Trials Collaborative (RI-CCTC) at Hasbro Children's Hospital, Women & Infants
Hospital and Brown University, is an ideal clinical center for the ECHO ISPCTN. We will build on our successes
in the initial award period, in which we were a top enrolling site, developed a new network neonatal opioid
withdrawal trial protocol, and provided leadership to the network through our committee work. Our state's
demographic includes many underserved, minority and immigrant children, who have high rates of infant
mortality, asthma, obesity, prematurity, mental health problems and special health care needs. This high risk
population has not been previously included in many clinical studies, and thus is benefitting both directly and
indirectly from the RI-CCTC's work. Rhode Island is uniquely organized for population-based clinical research:
it has one major obstetric hospital (80% of all deliveries in the state), one children's hospital (90% of all pediatric
admissions in the state) and one health department, as well as an engaged community. These factors allow for
effective enrollment, retention and follow-up of study participants in clinical trials, giving the RI-CCTC the
potential to make a strong impact. We have leveraged our rich network of collaborations with many existing
research, education and public health programs, as well as affiliations with national research networks. These
partners share our commitment to children's health and child health research. The Brown University School of
Public Health and the Alpert Medical School, recently received a large gift to create the Hassenfeld Child Health
Innovation Institute (HCHII), which is focused on understanding the prenatal, perinatal and postnatal factors that
lead to childhood asthma, obesity and autism. The RI-CCTC will leverage the resources of the HCHII to create
a much broader and more powerful research network to serve children in the state of RI. Investigators in the
Schools of Public Health and Medicine have considerable expertise in the study of environmental exposures and
their impact on children. The contact PI, Thomas Chun MD, MPH, has extensive experience with multi-center
networks and their leadership, through his experience with the ECHO ISPCTN and the Pediatric Emergency
Care Applied Research Network. Co-PI Abbot Laptook similarly is a leader in both the ISPCTN and the NIH
funded Neonatal Research Network. Senior Faculty Development Leader and co-PI Phyllis Dennery MD, has
had consistent NIH funding for her basic/translational research, has participated in many training grants and
multicenter clinical trials, and has won mentoring awards. This team will ensure the continued success of the RI-
CCTC in fulfilling the goals and mission of the ECHO Program. Our Specific Aims are to: 1) Continue to provide
new opportunities for underserved patient enrollment in ECHO ISPCTN studies by building on our current
collaborations between our academic research centers and institutions; 2) Continue to provide leadership to
the ECHO ISPCTN and ECHO Program by developing new clinical trials and serving on network committees;
3) Develop and expand programs to educate and mentor clinicians to become independent investigators.

Public health relevance
The objective of the RI-CCTC is to enhance the health of children for generations to come, by building on our successes in the ECHO ISPCTN and ECHO Program in the initial award period. The RI-CCTC has built a robust research infrastructure, been a top site in enrolling participants and developing new clinical trials, and enhanced research capacity by developing and mentoring new investigators. Rhode Island offers a unique and diverse population of children to achieve the goals of the ECHO program.